Neurobehavioral consequences of Mild Traumatic Brain Injury and addiction risk: a cotwin-control study

Project Summary/Abstract
The overall goal of the proposed study is to identify long-term neurobehavioral consequences of childhood mild
traumatic brain injury (mTBI) for the developing brain and examine their contribution to addiction risk using a
rigorous cotwin-control design, longitudinal follow-up, and multimodal and innovative neuroimaging tools and
neurobehavioral assessments. mTBI sustained during childhood or adolescence, periods of continuing brain
development and reorganization, is a major public health problem due to its high prevalence and long-lasting
neurobehavioral consequences associated with increased risk for addictive behaviors. However, progress in
understanding long-term sequelae of mTBI and their role in addiction is hindered by a number of significant
methodological challenges: a) case-control studies are correlative and do not allow to distinguish consequences
of TBI from pre-existing neurocognitive deficits potentially increasing the risk for TBI; b) matching cases and
controls is very problematic due to substantial (and largely heritable) individual variability in brain structure and
function and heterogeneity of brain damage; c) single neuroimaging modalities provide only a limited insight into
the consequences of mTBI; d) in cross-sectional studies, the effects of mTBI may be confounded with the effects
of substance use. The proposed study will address these critical barriers to progress using a combination of
rigorous and innovative approaches: (i) the co-twin control design that will provide the best-possible controls for
mTBI cases - their monozygotic co-twins without TBI history, (ii) multimodal neuroimaging assessments
leveraging high spatial resolution of MRI and high temporal resolution of brain electrophysiology, and (iii) a
longitudinal follow-up assessment of changes in substance use behaviors (onset, regular use, substance use
disorder symptoms). Assessment will include structural, functional, and diffusion MRI, quantitative Gradient
Recalled Echo (qGRE) MRI, a novel neuroimaging technique sensitive to cortical cellular microstructure, brain
neurophysiology including resting-state EEG, and event-related brain potentials (ERP), methods that are
sensitive to abnormal timing and synchrony of neuronal dynamics. The following Specific Aims will be pursued:
Aim 1: To identify long-term consequences of mTBI in early adolescence and distinguish them from pre-existing
factors potentially associated with risk for mTBI using a cotwin control design. We hypothesize that, in mTBI-
discordant monozygotic pairs, twins with lifetime history of mTBI will show alterations in brain structure and
function and deficits in neuropsychological performance compared with their cotwins without mTBI history; Aim
2: To determine, both cross-sectionally and prospectively, whether mTBI is associated with elevated risk for
addictive behaviors. A better understanding of the mechanisms by which long-lasting neurobehavioral
consequences of childhood and adolescent mTBI contribute to addiction risk will inform the development of more
efficient treatment and rehabilitation approaches, as well as prevention of substance use and abuse and mental
illness in youth with a history of mTBI.

Public health relevance
PROJECT NARRATIVE Mild traumatic brain injury (mTBI) is highly prevalent and can potentially have long-lasting consequences for the brain, cognitive function, and behavior, including elevated risk for substance abuse and psychopathology. In this study, we will use a powerful and rigorous cotwin control approach to identify causal effects of TBI by comparing twins with mTBI history with their identical cotwins who never had a TBI. A better understanding of long-lasting consequences of childhood and adolescent mTBI will promote the development of more efficient treatment and rehabilitation efforts, as well as prevention of substance abuse and psychopathology frequently associated with mTBI history.